Climate & Health Actionable Research and Translation Center

CHART: COMMUNITY ENGAGEMENT CORE – SUMMARY
The Community Engagement Core (CEC) of the CHART Center seeks to solidify an equitable partnership with
community leaders and key stakeholders in climate and health to strengthen the resilience of Atlanta
neighborhoods to the impact of climate change on health. We utilize innovative methods of community and
stakeholder engagement to actively engage partners, including under-resourced and climate-impacted
communities, in all phases of current and future center research projects with the goal of creating tangible
benefits in Atlanta and beyond. We apply principles of community-based participatory research (CBPR),
systems science, and concept mapping to prioritize actionable research and support residents to implement
projects to strengthen their adaptive capacity to the impact of climate change on their health. The CEC
provides opportunities for bidirectional learning in alignment with the principles of CBPR to build and sustain
equitable partnerships. We achieve the CEC objective through the following specific aims: 1) maintain and
expand multi-directional dialogue and collaboration around climate, health, and justice with Atlanta-area
communities most impacted by heat exposure and other climate hazards, 2) enhance community capacity to
address local climate change and health concerns, and 3) guide CHART Scientists in community engagement
and community-engaged research. By the end of the project period, the CEC will have established a strong
and diverse Partner Steering Committee that has a meaningful role in the CHART Center. We will have
supported bidirectional learning that has enhanced local communities’ capacity to address climate and health
priorities and has strengthened the capacity of CHART scientists to partner with communities in equitable and
actionable research. This work will lay a solid foundation for a sustainable partnership that will work
collaboratively to strengthen the resilience of priority communities in Atlanta and beyond to address the impact
of climate change on health.